Minimizing Uncertainty in Breast Ultrasound Imaging with Real-Time Coherence-Based Beamforming

Project Summary
Approximately 280,000 women are expected to be diagnosed with breast cancer in the United States in 2021
and more than 40,000 will die from the disease. It is well documented that early detection results in improved
morbidity and mortality. Ultrasound imaging is an important screening and diagnostic breast cancer detection
tool, particularly for women with dense breasts when mammography tends to be suboptimal. While suspicious
ﬁndings may be clariﬁed with ultrasound imaging, a subset of ultrasound images yield inconclusive results, ne-
cessitating biopsies or follow-up imaging, which increase patient anxiety and places additional burdens on the
time available for clinical care and the resource allocations of our healthcare system. One reason for this out-
standing challenge is that dense breasts tend to create images with signiﬁcant acoustic clutter, which confounds
the differentiation of an otherwise anechoic mass (which is indicative of a benign cyst) from a truly hypoechoic
mass (which could be indicative of malignancy). In addition, it can be difﬁcult to distinguish a complicated cyst
(which has internal echoes due to proteinaceous material and is benign) from either a solid mass or a complex
cystic and solid mass (which could be malignant) using standard ultrasound imaging methods alone.
The objective of this proposal is to develop new, real-time ultrasound imaging technology that will simplify clin-
ical workﬂows by distinguishing ﬂuid-ﬁlled masses from solid masses and from complex cystic and solid masses,
which all appear hypoechoic in traditional ultrasound B-mode images. Our novel approach, Robust Short-Lag
Spatial Coherence (R-SLSC) imaging, has demonstrated feasibility to make this distinction by incorporating
coherence-based beamforming to augment existing beamforming methods available in clinical ultrasound scan-
ners. Aim 1 will focus on development of a real-time system for implementing matched B-mode and R-SLSC
imaging. Aim 2 will evaluate and compare real-time system performance. Aim 3 will assess the ability of our
novel methods to distinguish ﬂuid from solid or complex cystic and solid masses utilizing a combination of quanti-
tative analyses and task-oriented reader studies. Aim 4 will investigate advanced methods to retrieve coherence
information and diagnostic information regarding mass contents from ultrasound channel data, including recently
discovered options that rely on coherence lengths and lag-one coherence values without requiring reader input.
Successful completion of these aims will lead to a real-time, ultrasound-based tool to conﬁdently distinguish
solid from ﬂuid hypoechoic breast masses and provide a more simpliﬁed clinical workﬂow for the most challenging
of these cases. In addition, results from the proposed studies will be applicable to clarifying the content of masses
that may appear in multiple organs throughout the human body (e.g., testicular, liver, or pancreatic masses).

Public health relevance
Project Narrative Breast cancer is the leading cancer among women, accounting for one-third of diagnosed cancers. While sus- picious mammographic ﬁndings may be clariﬁed with ultrasound imaging, a subset of ultrasound images yield inconclusive results, necessitating biopsies or follow-up procedures, which increase patient anxiety and places an additional burden on the time and resources of our healthcare system. The goal of this project is to develop ultrasound technology that will resolve existing ambiguities.